Kidney Precision Medicine Project - Patient Engagement

Project Summary Abstract
The current understanding of the pathophysiologic and socio-economic processes that initiate CKD and
the paths by which they progress to ESRD are poorly understood, resulting in limited treatments. There is a
compelling unmet need for prospective studies to accurately phenotype patients with CKD using a combination
of kidney biopsy, clinical, biologic, and socioeconomic factors to develop individualized care to improve patient
outcomes. Over the past four years, at the local level we assembled a highly skilled, interdisciplinary team of
clinical researchers, physician-scientists, clinicians, research nurses, patient advocates and a Community
Advisory Board. This team designed, implemented and sustained a highly successful, ethically sound and safe
recruitment site (RS) for the Kidney Precision Medicine Project: 1) We performed the very first KPMP consortium
kidney biopsy in September 2019 and were the first RS in the consortium to perform 30 kidney biopsies,
successfully enrolling patients with a clinical diagnosis of hypertensive or diabetic chronic kidney disease and
yielding sufficient tissue for research protocols as well as for pathological diagnosis; 2) We collected and linked
clinical, biological and socioeconomic data of the biopsy participants; 3) We focused our efforts on African-
American and Latinx populations at a very high rate in order to address the disproportionate burden of CKD as
well as the historical lack of inclusion of these populations in cljnical research, mandated by the NIH, completing
22 out of 11 (73%) of biopsies among these groups. At the consortium level our team members have made
meaningful contributions to the major organizational and operational aspects of KPMP.
The main goal in this proposal will be population identification, patient recruitment and obtaining clinical
phenotype data, biosamples and kidney biopsies. To accomplish this goal we will 1) Identify, recruit, enroll, and
biopsy 34 patients annually from 3 large HS serving more than 51,996 patients with CKD and diabetes and/ or
hypertension and follow patients longitudinally; 2) Implement ethically-sound, systematic quality-assured
processes to obtain clinical and demographic data, bio-samples and kidney biopsies from patients with CKD in
a longitudinal clinical study; and 3) Develop and implement patient-centered processes to promote long-term
engagement and retention of study participants in KPMP. Our successful track record as a recruitment site for
procurement of kidney tissue from patients with CKD attributed to diabetes or hypertension from a large, diverse
patient population makes us an ideal site for the continuation of the KPMP. Our ability to recruit patients from
multiple health systems with novel informatics tools, an ethically rigorous approach to consenting for kidney
biopsy and coupled with a rigorous and safe methodology is a powerful combination we bring to the KPMP. Our
innovative approach to this FOA will not only provide the data to generate new knowledge to improve both the
diagnosis and treatment of CKD, but also serve as a model for future kidney precision medicine initiatives and
their expansion over time.

Public health relevance
Project Narrative Patients with chronic kidney disease have a higher risk for early death and kidney failure. In this study we will collect medical and socioeconomic information from patients, blood and urine samples and do a kidney biopsy to obtain samples of kidney tissue. The information will be used to understand what leads to the progression of kidney disease and to develop new treatments to avoid future complications in patients.